A Low-cost Automated and Noninvasive Tool for the Assessment of Cognition in Infants and Toddlers

In this fast track SBIR project, Koronis Biomedical Technologies (KBT) will develop a low-cost neuro-cognitive assessment tool for infants and pre-school children. Non-invasive neuro-cognitive assessments continue to be a very importance tool for monitoring infants and children to track normal-developing milestones, uncovering cognitive deficits and evaluate treatment effectiveness. Low-cost, and easy-to-use tools that are standardized and widely accessible with cross-culturally appropriate designs for resource limited settings are low. Current assessments typically require highly-trained personnel to perform and interpret testing measures. KBT in collaboration its research partners will develop a set of interactive assessment videos that operate on low-cost commercially available tablets (Apple IPAD and Android-based tablets). The age-appropriate videos will automatically evaluate the cognitive assessment across multiple domains using highly accurate infrared eyetracking hardware/software directly interfaced with the tablet. The infrared eye-tracking technology is based upon and an evolution of very sophisticated and well established methods used in neuro-cognitive studies at university research labs. In phase I, a human pilot feasibility study will be performed using one cognitive domain set (executive function). The phase II activities will focus on finalizing the pre-production prototype system, finalizing and incorporating a full set of cognitive domains, performing a human validation study along with a comprehensive normative study.

Public health relevance
There is a great need for standardized (reliable, valid, normed) non-invasive measures of key neurocognitive functions in infancy and childhood, which would allow for the routine screening of neurocognitive health at an early age (e.g. 12 months), allowing for the early detection of potential difficulties and more timely intervention.